A MULTICENTER TRIAL OF PREDNISONE IN ALZHEIMERS DISEASE

This protocol will determine whether treatment with prednisone will slow the rate of progression of Alzheimer's disease (AD), and whether serum levels of the acute phase reactants C-reactive protein (CRP) and beta-1 antichymotrypsin (ACT) are useful in guiding anti-inflammatory therapy in AD.